Metabolic reprogramming to boost the fitness of anti-tumor immunity against metastatic colon cancer

Abstract
The primary goal of this project is to enhance the efficacy of immunotherapy against metastatic colorectal cancer
(mCRC) by activating the peroxisome proliferator-activated receptor delta (PPARδ)-Carnitine
palmitoyltransferase 1a (Cpt1a) axis in CD8+ T cells. Colorectal cancer (CRC) is among the deadliest cancers
worldwide, with rising incidence and mortality in younger populations. Particularly, mCRC patients, predominantly
of the microsatellite stable (MSS) subtype, show poor responsiveness to current immunotherapies due to the
immunosuppressive tumor microenvironment and low mutation burden that associates with limited
immunogenicity. This creates an urgent need for innovative approaches to boost the immunogenicity and
improve treatment outcomes. Our preliminary studies highlight the role of PPARδ, a lipid-sensing transcription
factor, in modulating the metabolic fitness of CD8+ T cells within the tumor microenvironment, thereby enhancing
their immunogenic potential against mCRC. We found that by promoting mitochondrial fatty acid oxidation (FAO)
through the PPARδ-Cpt1a axis, we could significantly augment the efficacy of existing immunotherapies. The
roles of PPARδ and FAO in tumorigenesis and immunity are controversial due to lack of cell type-specific genetic
loss-of-function and gain-of-function models. We hypothesize that the metabolic competition between cancer
cells and the immune system is a critical determinant of immune cell fitness against cancer. By activating PPARδ
in CD8+ T cells, we aim to tip this balance to enhance immune cell function and thus improve the anti-tumor
efficacy of immunotherapies in mCRC. To achieve our goal, we propose three synergistic aims. First, we will
delineate the specific mechanisms by which PPARδ activation enhances the anti-tumor activity of CD8+ T cells
in the context of MSS mCRC, focusing on their anti-metastatic function and the underlying epigenetic alterations.
Second, we will elucidate the role of Cpt1a-mediated fatty acid oxidation in the context of PPARδ-induced
modifications in CD8+ T cells, assessing how these metabolic changes impact their effectiveness against cancer.
Finally, we will evaluate the therapeutic potential of enhancing the PPARδ-Cpt1a axis within CD8+ T cells on the
efficacy of immunotherapeutic approaches against mCRC, using both murine models and human patient-derived
organoids to ensure clinical relevance. Collectively, this project is poised to transform mCRC treatment by
demonstrating that modulating the metabolic dynamics within the tumor microenvironment can substantially
improve immunotherapeutic outcomes. Successfully harnessing the PPARδ-Cpt1a axis in immune cells holds
the promise of developing new therapeutic modalities that significantly extend survival and enhance the quality
of life for mCRC patients, who suffer from lack of effective treatment options.

Public health relevance
Project narrative This research aims to explore new ways to treat metastatic colorectal cancer (mCRC), a disease that currently has limited treatment options and is a leading cause of cancer-related death. We focus on understanding how metabolic activity within immune cells can be manipulated to boost their ability to fight cancer. By identifying and targeting elements that improve metabolic activity of immune cells, we hope to enhance existing cancer therapies, potentially extending survival and improving the quality of life for patients with mCRC.